Administrative and Translational Research Support Core

Abstract Core A is functionally the administration and clinical research support Core which will provide essential support for all administrative activities and clinical trial-associated activities of this Program Project Grant (PPG). The administrative components of the Core will provide support for accounting, budgeting, fiscal reporting and communication while the clinical research support components will facilitate protocol activation and execution as well as effective dissemination of information between program sites (ie Adult BMT Clinical Units on the University Campus and Pediatric BMT Clinical Units on the Riverside Campus). Clinical research support activities will include preparation and distribution of protocol revisions, research sample calendar monitoring, collection, tracking and distribution to research laboratory sites as well as monitoring supply procurement and distribution for centrally purchased materials needed for the clinical trials. The Core responsibilities will also include protocol monitoring and communication among project and Core key personnel through in-person meetings, regularly scheduled conference calls, and additional telephone communication. Additionally, the Core will support scheduling and coordination of internal research meetings and external consultant visits. This Core will be led by Dr. John Wagner. The Specific Aims of the Core are to provide administrative support, scientific oversight, clinical oversight and promote PPG interactions and collaborations.

Public health relevance
Public Health Relevance The administration and clinical research support Core will provide essential support for all administrative activities and clinical trials associated with the program project grant. The administrative components of the Core will provide support for accounting, budgeting, fiscal reporting and communication while the clinical research support components will facilitate protocol activation and execution as well as effective dissemination of information between clinical sites. Optimization of infrastructural support, improved integration from multiple sources and timely and complete collection of planned blood and tissue samples for proposed laboratory evaluations will accelerate discovery, ultimately improving the health of the patients with high risk malignancy.